CE19-001, The University of Iowa Injury Prevention Research Center

UI IPRC Abstract 2019-2024
Established in 1991, the University of Iowa Injury Prevention Research Center (UI IPRC) aims to prevent,
control, and optimize recovery from injuries and violence, especially in rural communities. The UI IPRC has
grown to include 66 researchers from 25 departments, as well as a wide network of community and
government collaborators. Over the next 5 years, the UI IPRC will conduct innovative and multidisciplinary
research, training, and outreach. The UI IPRC will be led by an efficient organizational structure that promotes
engagement and communication across staff, students and collaborators. A Leadership Team oversees daily
operations, informed by an Executive Committee that assists in implementing our vision, 4 Cores, 6 Expert
Research Teams and 4 small research projects. The Administrative Core, Outreach Core, Training and
Education Core, and Research Core provide services to UI IPRC partners and ensure rigor and continuity
throughout our activities. The 6 Expert Research Teams are organized around established areas of expertise:
Opioid Overdose; Road Traffic Safety; Interpersonal Violence; Intervention and Translational Research; Older
Adult Falls; and Rural Acute Care. Teams promote the growth of research by linking researchers to UI IPRC
Core services, mentoring students and junior faculty, and engaging with community partners. The UI IPRC is
guided by a Community Advisory Committee, an External Advisory Committee, and an Evaluation Team that
together ensure strong engagement and broad input. These entities have engaged in our UI IPRC Strategic
Plan, Communication Plan, a social media plan, and protocols for influencing policy. Our 4 independent
research projects address NCIPC priority injury topics, including opioid overdose and adverse childhood
experiences, as well as a translation project. Our project focused on adverse childhood experiences uses data
from a longitudinal cohort of African American men to examine the role of child adversity on cardiac health,
with incarceration as a moderating factor. Our opioid overdose project partners with a rural hospital network to
examine the implementation of an opioid management plan for older adults, and its impact on fall risk. Our
translational research project partners with our NCIPC-funded Rape Prevention and Education program to
translate an evidence-based sexual assault prevention program into rural schools. And, our final project
partners with 13 state Departments of Transportation to evaluate the impact of policies for older adult drivers'
licensing on crash risk. We support research through a competitive Exploratory Grant program sponsored
annually by $90,000 in institutional commitment. In summary, the UI IPRC's proposed activities constitute
broad, multidisciplinary and collaborative program in research, training, and outreach.

Public health relevance
Project Narrative – University of Iowa Injury Prevention Research Center The University of Iowa Injury Prevention Research Center (UI IPRC) aims to prevent, control, and optimize recovery from injuries and violence, especially in rural communities. The UI IPRC works toward this goal through research, training, and outreach, focusing on rural populations and a variety of injury types, and striving to optimize our impact on the field. The UI IPRC will continue its strong tradition of multidisciplinary and collaborative activities that engage diverse areas of expertise and multiple local, state, and national partners.